Molecular and genetic studies of NMNAT2 in neuroprotection

PROJECT SUMMARY / ABSTRACT
The high and increasing prevalence as well as the staggering social and financial costs of Alzheimer’s Disease
(AD) and AD-related dementia (ADRD) emphasize the importance of finding strategies to prevent or slow their
progression. Here we aim to elucidate the basic biology of neuronal maintenance and energy homeostasis to
enable us to design new therapeutic strategies independent of tau or beta-amyloid theories. Almost all neurons
are born early in life and require an active neuroprotection program for their survival in response to the myriad
of internal and external challenges they face throughout life. NMNAT2 is a bifunctional protein that we and
others have identified as an important neuronal maintenance factor. NMNAT2 synthesizes nicotinamide
mononucleotide (NAD+) and serves as a molecular chaperone for day-to-day axonal function and to protect
neurons from proteinopathies such as hyperphosphorylated tau. In AD patients, NMNAT2 abundance is
greatly reduced to less than 50% of normal level and its level correlates with cognitive function. We found that
deleting NMNAT2 from mouse cortical glutamatergic neurons results in AD/ADRD-like phenotypes, such as
glucose hypometabolism, axonopathy and neuroinflammation. The current mouse and human results strongly
support a causal relationship between NMNAT2 hypofunction and neurodegeneration.
Axonal degeneration is a key step in AD/ADRD and many neurodegenerative diseases. Axonal
transport plays critical roles in neuronal function and survival and is extremely energy demanding. Abnormal
axonal transport is an early defect in axons destined to degenerate. Increasing evidence reveals dysregulated
glucose metabolism in AD. Our preliminary studies suggest that NMNAT2 plays a critical role in fast axonal
transport by maintaining axonal energy homeostasis. Deleting NMNAT2 in glutamatergic neurons reduces
glycolysis while at the same time augmenting the pentose phosphate. These findings raise the following
questions: Does NMNAT2 in glutamatergic neurons play essential roles in maintaining energy homeostasis for
normal axonal function? Does glucose hypometabolism caused by loss of NMNAT2 cause axonopathy? Will
supplement strategies bypassing NMNAT2 support neurons and attenuate axonopathy? To answer these
questions, we propose the following aims:
1. Test the hypothesis that NMNAT2 is required in cortical neurons for axonal transport.
2. Test the hypothesis that NMNAT2 contributes to axonal energy homeostasis.
3. Test the hypothesis that NMNAT2 in cortical neurons is essential for glucose metabolism
The knowledge gained from our proposed studies will help us gain mechanistic understanding into how
NMNAT2 contributes to active neuronal maintenance and will provide necessary insights to assist in drug
discovery using NMNAT2 as a therapeutic target for neurodegeneration.

Public health relevance
PUBLIC HEALTH RELEVANCE More than six million Americans suffer from neurodegenerative diseases, for which there are no good treatments. We are studying how a protein called NMNAT2 provides neuroprotection in the mammalian central nervous system with a long-term goal of developing therapies to treat neurodegenerative diseases, including Alzheimer's disease and Alzheimer’s disease related dementia.